The development of delta opioid receptor agonists for the treatment of opioid withdrawal associated behaviors

Project Summary
Chronic opioid use can lead to opioid induced hyperalgesia (OIH), which is a paradoxical increase in pain
sensitivity. Currently, the only specific treatment for OIH is opioid cessation. However, during this abstinence
period, patients suffer from their untreated pain as well as opioid withdrawal; and the majority of patients relapse
within the first year. As a result, OIH patients are particularly vulnerable to the development of opioid use
disorder. Novel targeted therapies that could alleviate OIH would result in decreased prescription opioid misuse
and abuse. The Pradhan lab has recently shown that δ opioid receptor (δOR) agonists can reduce OIH in a mouse
model. However, the development of δOR agonists has been limited by seizurogenic activity and tolerance. These
adverse effects appear to be ligand biased, and δOR agonists which favor G protein signaling over β-arrestin
recruitment have a reduced propensity to induce analgesic tolerance and pro-convulsant effects. PharmNovo has
developed novel G protein biased δOR agonists. Their lead compound, PN6047, is pre-clinically safe and effective
in animal models of chronic pain; does not produce convulsions and, shows little analgesic tolerance. The
objective of this proposal is to form an academic-industry collaboration to evaluate novel biased δOR agonists
for the treatment of OIH. In the UG3 phase, the Pradhan lab will test PN6047 and another lead compound,
PN6041 which has higher G-protein bias, in their models of OIH. Dr. Jutkiewicz will test these lead agonists for
adverse effects in models of seizurogenic activity and abuse liability. In parallel, PharmNovo will use the two lead
compounds to design and synthesize a limited catalogue of novel ligands with the aim to obtain the optimal
properties of high selectivity and potency, G protein bias, and good CNS penetrance. These compounds will be
screened in vitro by the Kelly Lab. The critical Go/No-Go milestone necessary to progress to the UH3 phase will
be the identification of at least one lead compound that is effective in models of OIH, is non-seizurogenic, lacks
abuse liability, and has a promising ADME/ toxicity profile; and if we produce at least 10 follow up agonists with
high selectivity and differential bias/efficacy. In the UH3 phase, approximately 12-15 compounds identified in
the UG3 phase will be fully characterized in cellular and brain membrane assays, with 6-10 of these tested for
efficacy in OIH models, for analgesic tolerance, potential development of opioid-induced hyperalgesia,
seizurogenic activity, and abuse potential. The most promising compounds will undergo commercial in silico and
in vitro ADME/PK and pre-regulatory toxicology testing. Finally, we expect that an emergent lead compound
will be suitable for in vivo acute toxicology, dose range finding/maximum tolerated dose testing and, if possible
within timescale and budget, repeated dose toxicity studies. If fully successful, the project will have generated a
novel, optimized δOR agonist ready to enter Regulatory Toxicology, as a prelude for human testing as a treatment
for OIH.

Public health relevance
Project Narrative Opioid-induced hyperalgesia (OIH), is a paradoxical increase in pain caused by long term use of prescription opioids. This project is an academic/industry collaboration that aims to produce a completely novel type of opioid medicine, a delta opioid receptor (δOR) activator to treat OIH. New δOR compounds will be made and tested in state of the art models of OIH with the intention of bringing at least one compound to the final stage of drug development prior to human clinical trial.